Mentoring patient-oriented translational research in tuberculosis

Project Summary
Tuberculosis remains one of the leading causes of death worldwide, despite the widespread availability of
effective treatment and prevention measures. To accelerate progress in reducing the global burden of
tuberculosis, there is a need for new tools and approaches to identify TB early, treat it effectively, minimizing
toxicities, and prevent new TB cases through preventive therapy. The overarching goal of this K24 award is to
train the next generation of scientists in patient-oriented, translational research on tuberculosis. Dr. Jason
Andrews is an infectious diseases physician-scientist who leads a research group focused on developing and
evaluating novel tools, from the laboratory to the field. He has served as a mentor to 30 students and
postdoctoral fellows and is the primary mentor for three NIH career development awards. The proposed K24
award would: 1) protect his time to mentor early career investigators in patient-oriented research, investigating
critical problems in tuberculosis diagnosis, treatment and prevention; 2) enhance his skills in mentorship
through guidance from a committee of highly successful senior mentors; and 3) provide him opportunities for
professional development, including advanced training in pharmacogenomics, translational research and
personalized medicine. These proposed activities will leverage Dr. Andrews’ long-standing research
collaborations, including three active NIH-funded clinical studies in Brazil. This award would support new
studies to: 1) evaluate electrochemiluminescence assays for Mtb antigen detection in exhaled breath
condensates as a novel approach to active case finding for TB; 2) test for human genomic polymorphisms
associated with linezolid and bedaquiline metabolism and adverse events while validating a new amplicon-
sequencing pharmacogenomic assay; and 3) evaluate a novel approach to predicting isoniazid and rifapentine
metabolism by simultaneously measuring transcription of and polymorphisms in drug-metabolizing enzyme
genes. Overall, this proposed K24 award would provide critical support for mentoring early career scientists
while advancing innovative tools to improve the diagnosis and treatment of tuberculosis.

Public health relevance
Project Narrative Globally, tuberculosis is one of the leading causes of death by an infectious disease, and there is a critical need to develop new tools to enable early diagnosis and improve treatment and prevention. The proposed K24 award would support Dr. Andrews to mentor early career investigators in patient-oriented translational research. The focus of the proposed research is to test novel approaches to early diagnosis and pharmacogenomic approaches to optimize treatment and preventive therapy.